Longitudinal fMRI and DTI Studies of Mathematical Disabilities

DESCRIPTION (provided by applicant): Mathematical cognition is critical not only for success in science and engineering but also as an important skill in everyday life, second only to reading in formal education. Yet, mathematical difficulties are widespread in school-age children and college students in the US. Understanding the progression and mechanisms of mathematical development is a national priority, as emphasized by the conclusions of the President's National Mathematics Advisory Panel. Recent cognitive, developmental and educational studies have provided new insights into the enduring behavioral deficits in children with mathematical disabilities (MD). However, little is known about the neural and anatomical bases of MD in children. The overarching objective of our proposal is to continue a productive line of research investigating cognitive and brain mechanisms underlying MD in young children. We will use a cognitive and systems neuroscience approach coupled with state-of-the-art functional magnetic resonance imaging (fMRI), structural MRI and diffusion tensor imaging (DTI) techniques to achieve this objective. Our study focuses on ages 7-10 (grades 2, 3 and 4), a period important for mastering core arithmetic skills that support later mathematics learning. A prospective longitudinal design will be used to elucidate the neural correlates of poor arithmetic skills in children with MD and examine why some children with MD have persistent deficits whereas others do not. Our proposed studies focus on three groups of children: (1) children with mathematical learning disabilities (MLD) who have persistent disabilities (low achievement across grades), (2) low achieving but variable (LA-V) children who lag in performance skills in one year and are normal the next, and (3) typically developing (TD) children. We will characterize the behavioral, cognitive and neural profile of information processing deficits during addition and subtraction, two basic and complementary arithmetic operations that differ in task complexity and efficient retrieval. Analysis of DTI and fMRI data acquired from the same children will contribute important new knowledge about core neuroanatomical deficits in persistent MD. Novel multivariate pattern recognition techniques, which detect fine-grained differences in activation patterns, will be used to increase our ability to uncover aberrant neural representations of mathematical information in children with MD. The longitudinal study design will allow us to (1) assess intra- and inter-subject variability and stability of brain response and connectivity in relation to arithmetic skill development, and (2) identify latent classes of neurodevelopmental changes characterizing poor and normal development. Our proposed studies will provide new insights into the neural correlates of MD, and the extent to which increased recruitment of brain networks involved in arithmetic processing during development is altered in children with MD. By providing essential knowledge about the neurofunctional and neuroanatomical substrates of MD in children, and how they change with time, we will be able to inform the development of behavioral and educational strategies for improving mathematical skills at an early age.

Public health relevance
PUBLIC HEALTH RELEVANCE: Understanding the progression and mechanisms of mathematical development mathematical skills is a national priority, as emphasized by the formation of the President's National Mathematics Panel. Between 5 to 8% of children demonstrate some form of mathematical learning disability, with adverse life-long consequences for academic, vocational and professional success. The overarching objective of our proposal is to continue a productive line of research investigating the cognitive and brain mechanisms underlying MD in young children. Findings from our study will not only have important implications for determining mathematical learning in children, but also for understanding the cognitive and brain processes underlying mathematical learning disabilities. Project Narrative Understanding the progression and mechanisms of mathematical development mathematical skills is a national priority, as emphasized by the formation of the President's National Mathematics Panel. Between 5 to 8% of children demonstrate some form of mathematical learning disability, with adverse life-long consequences for academic, vocational and professional success. The overarching objective of our proposal is to continue a productive line of research investigating the cognitive and brain mechanisms underlying MD in young children. Findings from our study will not only have important implications for determining mathematical learning in children, but also for understanding the cognitive and brain processes underlying mathematical learning disabilities. __SpecificAimsTextDelimiter__ A. Specific Aims Mathematical cognition is critical not only for success in science and engineering but also as an important skill in everyday life, second only to reading in formal education [1]. Mathematical cognition provides a foundation for the development of skills that are becoming increasingly important in the 21st century [2, 3]. Yet, mathematical difficulties are widespread in school-age children and college students in the US [4]. Understanding the progression and mechanisms of mathematical development is a national priority, as emphasized by the conclusions of the President's National Mathematics Advisory Panel. Recent cognitive, developmental and educational studies have provided new insights into the enduring behavioral deficits in children with mathematical disabilities (MD)[5, 6]. However, little is known about the neural and anatomical bases of MD. The overarching objective of our proposal is to continue a productive line of research investigating the cognitive and brain mechanisms underlying MD in young children. We will use a cognitive and systems neuroscience approach coupled with state-of-the-art functional magnetic resonance imaging (fMRI), structural MRI and diffusion tensor imaging (DTI) techniques to achieve this objective. Our study focuses on ages 7-10 (grades 2, 3 and 4), a period important for mastering the core arithmetic skills that support later mathematics learning [7]. We will use a prospective longitudinal design to elucidate the neural correlates of poor arithmetic skills in children with MD and examine why some children with MD have persistent deficits whereas others do not. During the current project period, we have made significant progress in acquiring high quality cross-sectional and longitudinal neuropsychological, cognitive, and brain imaging measures of mathematical skills in over 100, 7-9 year old, children with MD and well- matched typically developing (TD) children. Specifically, we have been highly successful in acquiring fMRI and DTI data from children with MD and TD controls who are matched not only on IQ and gender but also on standardized measures of reading abilities, attention and working memory [8]. This data now provides us with a unique opportunity to address important questions regarding core deficits in MD uncontaminated by co-morbid disabilities. In the next project period, we will focus on comprehensive analyses of these data, and also enhance our ability to examine children with very low math achievement. Our proposed studies focus on three groups of children: (1) children with mathematical learning disabilities (MLD) who have persistent disabilities (low achievement across grades), (2) low achieving but variable (LA-V) children who lag in performance skills in one year and are normal the next, and (3) typically developing (TD) children. This variable achievement LA-V group provides a useful contrast for children with MLD, given similar achievement scores in at least one grade [9]. This will be the first brain imaging study of these groups and will allow us to (i) confirm behavioral studies suggesting delayed development, without any specific cognitive deficits, in children with LA-V, and (ii) investigate neural and cognitive factors that mediate poor development of mathematical skills in some children and normalization in others. If children with LA-V do not differ from TD children, the results will strengthen the conclusion that achievement levels at one grade level alone are not sufficient for diagnosing MD. If there are brain differences between the LA-V and TD groups, then these will suggest potential learning deficits in the former group that are not evident in behavioral measures. To achieve these goals, we will acquire additional longitudinal data and recruit more children with very low mathematical abilities, a group underrepresented in our current sample. In addition to conventional analysis of fMRI signal intensity, we will use multivariate pattern analysis (MPA) techniques to increase sensitivity for detecting processing deficits in children with MD, using novel methods developed in our lab [8, 10, 11]. We now also propose to examine the neuroanatomical basis of MD, following up on exciting preliminary findings suggesting impairments of both gray and white matter [8]. The Specific Aims of our proposal are: Angular gyrus Supramarginal gyrus Intraparietal sulcus Superior parietal lobule Figure 1: Parietal lobe regions that are of specific interest to the proposed studies, including the superior parietal lobule, angular gyrus, supramarginal gyrus and the intraparietal sulcus. Specific Aim 1: To investigate the neural basis of arithmetic skill deficits in a well-characterized group of 7- 9 year old children with MD. Rationale and Aims: The period between the ages of 7 and 9 represents an important period for mathematical skill development [12-22]. The ability to rapidly retrieve basic arithmetic number combinations is one of the most persistent deficits in children with MD [4, 23, 24]. We will characterize the behavioral, cognitive and neural profile of information processing deficits during addition and subtraction, two basic and complementary arithmetic operations that differ in task complexity and efficient retrieval [25]. We will examine how functional specialization develops, focusing particularly on posterior parietal cortex (PPC) regions (Figure 1) implicated in mathematical cognition [26-29]. Novel MPA techniques [10, 11, 30, 31], which detect fine- grained differences in activation patterns, will be used to increase our ability to uncover aberrant neural representations of mathematical information in children with MD. Cognitive function is critically dependent on the integration of information across multiple brain regions. We will therefore investigate how deficits in brain connectivity contribute to skill deficits in each mathematical operation [32]. Functional and effective connectivity analysis [33-35] will be used to examine deficits in functional circuits linking regions of interest in the PPC, inferior temporal cortex, medial temporal lobe (MTL) and prefrontal cortex (PFC) [36]. Specific Aim 2: To investigate the neural basis of persistent arithmetic skill deficits in 7-10 year old children with MD using a longitudinal design. Rationale and Aims: Behavioral studies have suggested that some children have persistent deficits in basic mathematical skills while others have more variable achievement scores [37]. Here we propose to investigate the neural basis of individual differences in the development of arithmetic skills and to map differential growth trajectories in children with MLD and LA-V, in comparison with TD children. Our longitudinal study design will, for the first time, allow us to assess (1) intra- and inter-subject variability and stability of brain response and connectivity in relation to arithmetic skill development, and (2) latent classes of neurodevelopmental changes characterizing poor and normal development in 7-10 year old children [38]. We will also employ novel MPA to identify anatomical networks that distinguish children with MLD from LA-V children. Functional and effective connectivity analysis [33-35] will be used to compare developmental changes in functional circuits important for mathematical cognition. Specific Aim 3: To investigate the neuroanatomical basis of persistent MD in 7-10 year old children using a longitudinal design. Rationale and Aims: A rapidly emerging body of research suggests that experience shapes white and gray matter in the learning brain [39]. DTI studies are now also beginning to suggest that neural plasticity during development and learning is also accompanied by significant structural changes [40, 41]. Almost nothing is currently known about the neuroanatomical basis of poor mathematical skill development in young children with MD. Here we propose to examine white and gray matter deficits underlying MD in children. We have recently shown that children with MD may have significant impairments of white and gray matter [8]. To follow up on these exciting preliminary findings, we will first validate our previous findings on an independent sample of children with MD and well-matched TD controls. We will then compare longitudinal changes in white matter pathways in children with persistent MD. Changes in micro-structural and macro-structural integrity of white matter pathways, including fractional anisotropy (FA), mean diffusivity, white matter density, as well as fiber tract mapping [8] will be investigated in relation to developmental changes in mathematical ability. Analysis of DTI and fMRI data acquired from the same children will contribute important new knowledge about core anatomical deficits that contribute to persistent MD. The proposed studies will characterize differential neurodevelopmental changes in young children with MD, and examine how these changes are related to increased task proficiency and overall mathematical abilities. The longitudinal study design will allow us to (1) assess intra- and inter-subject variability and stability of brain response and connectivity in relation to arithmetic skill development, and (2) identify latent classes of neurodevelopmental changes characterizing poor and normal development [38]. Our proposed studies will provide new insights into the neural basis of correlates of MD, and the extent to which increased recruitment of brain networks involved in arithmetic processing during development is altered in children with MD. By providing essential knowledge about the neurofunctional and neuroanatomical substrates of MD in children, and how they change with time, we will be able to inform the development of behavioral and educational strategies for improvement of mathematical skills at an early age.